GM-CSF and STAT5 signaling axis as regulator of Trem2+ macrophage fate specification in the heart

PROJECT SUMMARY
Cardiovascular disease is the leading cause of death worldwide. While current heart failure therapies
primarily target neurohormonal pathways driving adverse remodeling, they do not address inflammation, a key
contributor to cardiac dysfunction and fibrosis. Recent studies have highlighted the importance of monocyte-
derived macrophages marked by C-C chemokine receptor 2 (CCR2) in cardiac inflammation and remodeling.
These CCR2+ macrophages arise from highly plastic monocytes and form a heterogeneous population with
both inflammatory and reparative functions. However, little is understood about the mechanisms that govern
monocyte fate specification in the heart.
This project investigates the GM-CSF/STAT5 signaling axis as a critical regulator of CCR2+ monocyte
fate specification during cardiac injury. GM-CSF (Csf2) signaling, which drives STAT5-mediated transcription of
inflammatory genes, is upregulated following cardiac injury. My central hypothesis is that GM-CSF signaling to
heart-infiltrating monocytes regulates monocyte differentiation, controlling the specification between
inflammatory and reparative macrophage states, a process critical for cardiac repair. Supporting this
hypothesis, I found that Stat5 deletion in CCR2+ monocytes reduced cardiac inflammation and improved
cardiac function in two distinct murine heart failure models. Importantly, I used single-cell RNA sequencing to
identify cardiac macrophage states, and I demonstrated that Stat5 deletion reduces inflammatory macrophage
subsets and enriches a macrophage population expressing high levels of Trem2 (triggering receptor expressed
on myeloid cells 2). Trem2+ macrophages are implicated in resolving inflammation and promoting tissue repair
in other organs, but their specification and functional roles in the heart remain unexplored.
Aim 1 of this proposal elucidates mechanisms of Trem2+ macrophage specification and fate maps their
lineage in the heart. Aim 2 investigates the functional roles of Trem2+ macrophages in murine models of heart
failure. By addressing critical gaps in our understanding of CCR2+ monocyte fate specification and the identity
and function of Trem2+ macrophages, this work will inform novel therapeutic strategies targeting specific
macrophage states to mitigate inflammation in cardiac disease—maximizing treatment efficacy while
minimizing off-target effects.

Public health relevance
PROJECT NARRATIVE Heart failure is a leading cause of morbidity and mortality, affecting over 64 million people worldwide. Emerging evidence highlights cardiac macrophage identity as an important determinant of outcomes after cardiac injury, but the mechanisms driving macrophage differentiation and the impact of this process in heart failure are not fully understood. This proposal aims to uncover how cardiac macrophage identity is determined following heart injury and identify new therapeutic strategies for heart failure patients.